MHC Variation in Host Response to SARS-CoV2 and COVID-19 Outcomes

SUMMARY
Located within the human Major Histocompatibility Complex (MHC) chromosome 6p21, the Human Leukocyte
Antigen (HLA) region is the most medically important region of the human genome. Variation in the HLA region
has been associated with over 150 diseases and conditions, including infectious disease, cancers, and major
drug-hypersensitivities. While little is known at this point about the impact of host genetic factors in COVID-19,
the epidemiology to-date reveals wide variation in disease course among confirmed cases of infection that does
not appear to be fully explained by known risk factors. Because of its pivotal role in the immune response
understanding the role of HLA variation promises to provide important insights relevant to understanding the
immunopathogenesis of COVID-19, while informing vaccine development and potential immunotherapies. In
Specific Aim 1, we will exploit an existing data resource, partnering with the National Marrow Donor Program
and DKMS registries to collect data on COVID-19 symptoms, testing and outcomes using a novel, validated
smartphone app in a very large sample (N=300,000-500,000) of volunteer bone marrow donors with pre-existing
HLA genotyping data, allowing an extraordinarily well-powered examination of the role of these genes in disease.
In Specific Aim 2, we will employ a novel, validated method for next-generation sequencing of the extended MHC
(~5Mb), including all classical and non-classical HLA loci, as well as over 150 additional immune system loci, in
large and diverse cohorts of COVID-19 patients (N=2000), as well patient cohorts with longitudinal clinical data
and extensive immunoprofiling (N=300). Finally, in Specific Aim 3 we will contextualize these association studies
through examination of the role of HLA presentation of SARS-CoV-2 antigens. In summary, we will leverage
large and diverse patient cohorts alongside cutting edge technology and molecular biology to reveal the role of
these important immune loci in COVID-19.

Public health relevance
Project Narrative The major genetic contribution of the human leukocyte antigen (HLA) region to disease risk has been recognized for nearly fifty years, with hundreds of associations observed in autoimmunity, infectious disease, cancer, and major drug-hypersensitivities. Because of its pivotal role in the immune response to pathogens, we expect that HLA variation will also be found to play a role in SARS-CoV-2 infection and/or COVID-19 outcomes. Here, we will examine the association of HLA and other nearby genes with COVID-19 disease outcomes and explore the molecular basis for these associations.